SERVICES FOR CREATING A TOOLKIT FOR LEARNING AND PREDICTING ALCOHOL USE PATTERNS.

This contract is for a project titled, Toolkit for Learning and Predicting Alcohol Use Patterns (SBIR Phase I, Topic 019), and the purpose for this project is for creating a platform to accelerate alcohol research that consists of developing an innovative toolkit for learning and predicting alcohol use patterns and creating machine learning algorithms that are capable of analyzing high dimensional data, which shall have the ability to model the more complicated features inherent in biological data. In this Phase I project, the Contractor shall demonstrate the feasibility of the proposed platform by extending the support vector machines (SVMs) to handle random effects, profiling the algorithms through simulations, and applying the prototype platform to an NIAAA-sponsored longitudinal study of heavy drinkers. The data, algorithms, and results shall be packaged into interactive Jupyter notebooks for alcohol researchers to explore and compute risk in new patients.